Role of Gap Junction in Hypoxia-induced Pulmonary Hypertension

Project Summary/Abstract
Hypoxia induces pulmonary vasoconstriction by increasing smooth muscle contraction and attenuating
endothelium-dependent relaxation (EDR). Sustained pulmonary vasoconstriction and subsequent vascular
remodeling in small distal pulmonary artery (PA) are the major causes for the increased pulmonary vascular
resistance in patients with hypoxia-induced pulmonary hypertension (HPH). Endothelial dysfunction is implicated
in the development of many cardiovascular diseases including HPH and diabetes. EDR is mediated via different
mechanisms in small distal and large proximal arteries. Vasodilation in large proximal artery is mainly caused by
endothelium-derived nitric oxide (NO) and/or prostacyclin (PGI2), while vasodilation in small distal artery is due
prominently to endothelium-derived hyperpolarization (EDH). Gap junction (GJ) is an intercellular junction that
transfers small molecules and propagates electric signals (e.g., hyperpolarization) to adjacent cells. GJ is more
abundant in small distal artery compared to large proximal artery. We recently reported that diabetic mice
exhibited significantly increased sensitivity to develop HPH and diabetic patients have higher susceptibility to
develop pulmonary vascular abnormalities. It is, however, unknown whether alteration of endothelial function in
diabetes is involved in determining severity of HPH. The goal of this study is to investigate a) if and how
endothelial dysfunction in small distal PAs, as a result of dysfunctional GJ in endothelial cells (ECs), contributes
to the development and progression of HPH and b) if and how diabetes-associated GJ dysfunction exacerbates
HPH. Our preliminary data demonstrate that: i) small distal (4th-5th order) PAs, but not large proximal (1st-2nd
order) PAs, exhibit great EDH-dependent relaxation that can be attenuated by hypoxia; ii) pulmonary ECs from
HPH mice show lower protein level of connexin 40 (Cx40, a component of GJ) than ECs from normoxic mice; iii)
hypoxia attenuates GJ activity in pulmonary ECs, iv) Cx40 overexpression enhances EDH-dependent relaxation
and decreases right ventricular systolic pressure in HPH mice; v) hypoxic diabetic mice exhibit attenuated EDR
in small (4th-5th) PAs compared to hypoxic control mice; and vi) pulmonary ECs from diabetic mice show lower
Cx40 mRNA level than ECs from control mice. Based on these preliminary data, we hypothesize that a) chronic
hypoxia downregulates Cx40 expression, attenuates GJ function, impairs EDH-dependent relaxation in small
(4th-5th) PAs and, ultimately, induces HPH; and b) diabetes increases the susceptibility to HPH due to decreased
GJ activity. The specific aims are 1) to identify the molecular mechanisms by which chronic hypoxia attenuates
endothelial function in small distal PAs, 2) to investigate the pathogenic role of Cx40 in the development of HPH,
and 3) to examine the effect of type 2 diabetes on the development of HPH with a special focus on endothelial
GJ function. Completion of the proposed study will shed great lights into developing personalized therapies for
diabetic patients living at high altitude and/or have hypoxic cardiopulmonary diseases.

Public health relevance
Project Narrative Chronic hypoxia causes pulmonary hypertension (PH) that is a progressive disease characterized by elevated blood pressure in the lung. Endothelial cells regulate vascular tone and dysfunction of endothelial cells is implicated in many cardiovascular diseases including hypoxia-induced PH (HPH) and diabetes. In this project, we will investigate how endothelial dysfunction in distal pulmonary arteries contributes to the development of HPH and whether diabetes or hyperglycemia alters the susceptibility and severity of HPH. This study will also help develop personalized treatment for diabetic patients living at high altitude and have hypoxic cardiopulmonary diseases.